NEUROCOGNITIVE FUNCTION OF CHILDREN DIAGNOSED WITH DIABETES BEFORE AGE 10

The purpose of this protocol is to determine whether the administration of insulin can delay or prevent the development of insulin-dependent diabetes mellitus.